From synthetic bacterial adhesions to synthetic bacterial materials

Engineering of bacterial synthetic multicellular systems and materials hold promise for many health-
relevant applications such as modular drug biosynthesis, living diagnostic devices, and synthetic bioﬁlm research
models. To date, bacterial synthetic biology has largely focused on the scales of molecules and single cells.
Equivalent work on bacterial synthetic consortia is much less advanced, in signiﬁcant part due to the previous lack
of suitable synthetic and genetically encoded cell-cell adhesion tools to control the assembly, development, and
functionality of multicellular systems. We recently developed the ﬁrst such synthetic cell-cell adhesion toolbox, as
well as tools for optogenetically controlling cell-surface deposition and patterning.
The speciﬁc objectives of this research are to signiﬁcantly advance these synthetic cell-adhesion tools, and
to develop design principles and predictive modeling tools that enable consortia engineering and patterning that
integrate all relevant length scales (i.e., molecular, cellular, and multicellular), and ultimately pave the way for
medially relevant applications. Our main hypothesis is that we can signiﬁcantly advance our control over the
strength, speciﬁcity, and subcellular localization of synthetic adhesion proteins in Escherichia coli, which will
allow rational tuning of consortium-level biophysical properties such as porosity and viscoelasticity, and which
will ultimately enable versatile multicellular consortium engineering and patterning. This work will constitute
a foundation for various biomedical applications such as biocompatible materials, multicellular plug-and-play
pathway engineering, targeted in-vivo drug delivery, and living diagnostic devices.
Our interdisciplinary methodology combines synthetic biology, biophysics, instrumentation and modeling. All
experiments will be done in a quantitative manner. The proposed investigations include three independent yet
synergistic Speciﬁc Aims motivated by our hypothesis: (Aim 1) Advance the functionality of the synthetic adhesin
toolkit at the subcellular level; (Aim 2) Achieve engineering control over synthetic consortium properties such as
viscoelasticity and porosity at the scale of 10-100 µm; and (Aim 3) Achieve higher-level consortium patterning
on the scale of centimeters and demonstrate potential for medical applications.
The PI (Prof. Riedel-Kruse) and his team are well-suited for this project as we have signiﬁcant
expertise in synthetic biology, biophysics, instrumentation (e.g., microﬂuidics, imaging), and modeling genetic
circuits and biophysical systems across scales. We developed the ﬁrst synthetic cell-cell and optogenetic cell-surface
adhesion toolboxes in bacteria. Multiple collaborators provide additional domain expertise in key areas. Overall,
this project's innovation lies in establishing synthetic adhesins as an essential and integral component of the
synthetic circuit-engineering toolbox and in establishing a novel paradigm for modular engineering of multicellular
living materials. Accordingly, this project will broadly impact the engineering of synthetic consortia for basic
research as well as enable a dynamic spectrum of future applications in health.

Public health relevance
Bacterial synthetic multicellular systems and materials hold promise for many health-relevant ap- plications such as modular drug biosynthesis, living diagnostic devices, and synthetic bioﬁlm research models. Establishing control over the spatial, biochemical, and biophysical characteristics of synthetic consortia will be critical, but the key engineering tools such as synthetic cell-cell adhesins are still in their infancy. To close these major gaps, the proposed investigations will establish relevant synthetic tools, design principles, and modeling tools and deliver proof of principle of a new paradigm for modular engineering of synthetic multicellular bacterial consortia with desirable and tunable material properties and medical applicability.